CTL for supertype natural IgE cytotoxic peptide (nECP) to guard against allergic asthma

? DESCRIPTION (provided by applicant): Allergic asthma is a multi-faceted inflammatory disease in the lung. IgE and Th2-mediated inflammation play a critical role in extrinsic allergic asthma. Our labs have identified naturally processed IgE cytotoxic peptides (nECP) on IgE producing cells, which serve as CTL vaccine. The feasibility of using nECP with helper peptide PADRE as a universal IgE vaccine (or vaccine) to treat severe IgE-mediated allergic asthma is due to the following observations (preliminary results): (i) broad coverage of nECP supertype-based product concept for pan-IgE vaccine can be designed and applied to broad coverage of ethnically unbiased population. Second, progress was made for vaccine delivery platforms, e.g., transcutaneous immunization with nECP/PADRE in an FDA approved imiquimod for topical use, followed by nECP/PADRE in saline intranasally (IN). The mucosal immunization stimulating dendritic cells (DCs), and CD8 T cells enriched the lung to protect against IgE production in the rodent model. (iii) safety of the vaccine in its unique IgE isotype suppression, while sparing other antibody isotypes; and IgE recovery after the treatment window. (iv) testing human supertype nECP in the HLA-A, -B tg rodents, and in particular testing IgE suppression by in vitro nECP CTL immunization of human PBMCs, which suppress human IgE production. The goal is to develop a commercial product of supertype based universal IgE peptide vaccine with broad HLA-A,-B supertype coverage to treat IgE-mediated severe asthma. The vaccine will suppress human IgE producing B cells/plasma cells, including long-lived plasma cells in human lung in a safe IgE isotype-specific therapeutic window, permitting IgE recovery and parasite defense. The top priority is to compete studies in the rodent model and supertype composition of human nECP vaccine. The next Development Phase will require venture capital, the pharmas capital or licensing revenue, which is dependent on the completion of Research Phase of the three Aims proposed through this SBIR grant application for CMC or cGMP of vaccine manufacture. Our three aims are as follow: Aim 1. Evaluate efficacy and safety of a universal nECP asthma vaccine in the rodent model Aim 2. Evaluate the routes and mechanisms of therapeutic vaccination Aim 3. Evaluate a universal human nECP supertype asthma vaccine for 86% population coverage Milestones Aim 1 Aim 2 Aim 3 Year 1 Protection and recovery cycle; evaluating different helper peptides for sustaining protective CD 8 T cell responses; tolerant/unresponsive CD 8 T cells and restore responsiveness/breaking tolerance. The role of cDCs in the skin via TCI vaccination by FACS and analysis of migratory cDCs by T cell stimulation; the role cDCs via NALT and nasal tract in the B6 model; function of cDCs excluding blood monocytes. Evaluate high affinity human nECPs in A3 and more B7, A2 supertypes in inhibiting canonical peptide binding to purified HLA-A, -B. Year 2 Analysis of changes in B- cells and IgE plasma cells following CTL attack; IgE clearance; changes in submucosal mast cells, IgE/ mast cell axis after TCI/IN vaccination; AHR and Airway Remodeling analysis. Analysis of langerin+ DTR knockout of migratory CD103+ cDCs; Analysis of TCM, TEM and TRM In lymphoid and nonlymphoid organs after TCI or IN or TCI/IN, longevity of each subset with/without PADRE; in vivo conversion of TEM vs. TRM; the role of TCM. Tg studies for A3 supertypes in A3Kb tg mice, and more B7 and A2 supertypes in B7, A2 tg mice; high resolution mapping in human PBMC (also cryopreserved for a large aliquots) for combined supertype epitopes for vitro CTL for IgE suppression in vitro. Year 3 Confirm protection in airway inflammation and AHR in the Aspergillus fumigatus and cockroach models using TCI/IN vaccination. Analysis of trafficking in langerin+ CD103+ cDCs depletion alone vs. combined CD103+ cDCs and CD103+ TRM in CD103 knockout mice. Investigating the strength/magnitude by IFN-γ spots and lytic potential and quality of CTL of multiple supertype induced cultures, and expand into three additional supertypes: A1, A24 and B44 for high percentage human coverage.

Public health relevance
PUBLIC HEALTH RELEVANCE: IgE-mediated allergies are prevalent in near 30% of the US population; annually, allergy asthma alone costs more than 20 billion USD, and more than four thousand lives are lost each year. There is an urgent market need for a novel treatment in particular for IgE-mediated severe asthma. Anti-histamine and immunotherapy are effective for allergic rhinitis and other mild forms of allergy. Presently anti-IgE Xolair ($15,000 to $35,000 pe patient) is indicated for severe IgE-mediated asthma. However, Xolair does not permeate into the mucosal lung, which is an asthma shock organ. Recently efforts are made to develop active IgE B-cell vaccine eliciting broadly neutralizing anti-IgE in the lung. Although IgE B cell vaccine can temporarily neutralize secreted mucosal IgE, neutralizing antibodies do not eliminate or kill IgE- producing cells, in particular the long-lived IgE-producing cells in the lung parenchyma, which are culprits for persistent IgE-mediated severe asthma. Thus developing a cell immunity-based therapeutic vaccine, which elicits cytotoxic T lymphocytes (CTL) physically removing IgE-producing B and plasma cells is an urgent market need. This innovated CTL vaccine can be used to treat 5% or 1.4 million severe asthmatic patients. This product can likewise be extended to mild, moderate, and to moderately severe asthmatics as well. The product concept of a universal CTL peptide vaccine was first invoked for pan-IgE allergy therapy (PIT) (S.-S, Chen, IGE 1996), which was extended to the universal telomerase peptide-based cancer vaccine currently used in a clinical trial (Maurizio Zanetti, MZ, UCSD). This product concept also undergoes a profound undertaking in pan-herpes, arena-, dengue-, and the flu virus (Alessandro Sette, AS, LIAI). Rodent models are also developed for assessing the safety and efficacies of the asthma vaccine (M Croft, LIAI). With the combined expertise of the four Investigators, the goal is to eventually develop a commercial product of super-type based universal asthma vaccine for treating asthmatics across a broad ethnically unbiased spectrum of human population.